Mechanisms underlying establishment of regeneration competence

Planarian regeneration requires adult pluripotent stem cells, the source of all new tissues, and instructive cues from pre-existing tissues to re-establish polarity, patterning, and orchestrate differentiation of missing cell types. When and how embryos acquire regenerative abilities was not known. We discovered that regeneration competence is an emergent developmental property that seems to be limited by the development of somatic tissue(s) necessary for context-dependent regulation of stem cell dynamics after injury. We observe stage- and axial position-dependent effects on regenerative abilities late in embryogenesis, culminating in production of a fully regeneration-competent animal at hatching. Regeneration-incompetent animals, while able to regenerate posterior body structures, were incapable of regenerating new anterior (head) tissue. Ongoing work suggests that stem cell specification is not rate-limiting for establishment of regeneration competence: stem cells were present and cycling in regeneration-incompetent animals. We discovered that failure to reset the anterior-posterior axis underlies the head regeneration defect. RNAi knock-down of the Wnt pathway effector Beta-catenin-1 induced precocious head formation in regeneration-incompetent embryos, suggesting that high Wnt pathway activity inhibits anterior regeneration. Consistent with this result and in contrast to what was observed in regeneration-competent embryos, regeneration-incompetent embryos did not express Wnt pathway inhibitors, like notum, in anterior-facing blastemas. We are currently investigating how development of tissues that are transcriptionally responsive to wounding, including the body wall musculature, impinge on axial polarity re-establishment and acquisition of regeneration competence. Our results suggest that regeneration is regulated hierarchically, with master regulators of axial polarity governing regional patterning and organogenesis.